Research and Methods Core-002

RESEARCH AND METHODS CORE ABSTRACT
The Research and Methods Core (RMC) will serve as the hub in the University of Alabama at Birmingham
(UAB)'s Center for Cancer Control in Persistent Poverty Areas (C3P2) that (1) provides methodological
expertise on study design, analytic approaches, and statistical modelling to research projects, pilot projects,
and other Center-generated research; (2) promotes the use of common data elements across projects and
provide support on data measures, tools, integration, interoperability, and visualization; (3) provides expertise
on the use of implementation strategies and dissemination of research findings to multiple stakeholder groups
(e.g., investigators, community partners). The RMC will also play a critical role in supporting the research
projects, pilot projects under the Development Core, and early-career scientists under the Career
Enhancement Core. Additionally, in collaboration with Administrative Core, the RMC will participate in
connecting the C3P2 to the Persistent Poverty Initiative Network (PPIN) and evaluating its research
productivity and impact.